Modulating the Microbiome to Enhance Right Ventricular Function in Pulmonary Arterial Hypertension

Project Summary
The goals of this proposal are to help Sasha Prisco, MD, PhD, a cardiovascular physician-scientist, transition
to independence and to further the understanding of mechanisms of right ventricular dysfunction in pulmonary
arterial hypertension. Pulmonary arterial hypertension is a progressive vasculopathy which increases right
ventricular afterload, leading to right ventricular failure. Right ventricular function is the greatest predictor of
survival in pulmonary arterial hypertension. Unfortunately, there are no current pharmacologic therapies that
directly target the failing right ventricle. Our recent preclinical data demonstrated pathological inflammation
through activation of the cytokine receptor glycoprotein 130 induced deleterious microtubule remodeling,
downregulation of junctophilin-2 (an essential protein that maintains t-tubule structure and function), and
depressed right ventricular function in pulmonary arterial hypertension. Emerging data show alterations in gut
microbiota disrupt the intestinal barrier, which permits bacterial translocation, and subsequently activates
systemic inflammation, suggesting that modulating the microbiome may be an approach to mitigate
inflammation. We recently identified that modifying the gut microbiome with intermittent fasting improved right
ventricular function and postulate that increased abundance of Lactobacillus underlies these benefits. We will
test the hypothesis that Lactobacillus supplementation combats pathological gut dysbiosis, which prevents
immune cell activation, and subsequent glycoprotein 130-mediated microtubule remodeling in the following
specific aims. In Aim 1, we will determine if Lactobacillus supplementation mitigates pathological microtubule
remodeling and enhances right ventricular function in two rodent models of pulmonary arterial hypertension,
monocrotaline and Sugen-hypoxia. In Aim 2, we will investigate the effects of Lactobacillus supplementation on
gut dysbiosis and systemic inflammation. For this proposal, we will use a variety of approaches from
metagenomics analysis of the gut microbiome, SomaScan proteomics, and single-cell RNA-sequencing to
histological assessments, echocardiography, invasive hemodynamics, and treadmill exercise testing. This
project has the potential to identify a novel therapeutic approach for pulmonary arterial hypertension.

Public health relevance
Project Narrative This proposal is designed to further train Sasha Prisco, MD, PhD in molecular and cellular cardiac physiology and multiple omics techniques to help in the transition to becoming an independently funded physician-scientist who studies the mechanisms of right ventricular dysfunction in pulmonary hypertension. Her project investigates if Lactobacillus supplementation modulates the gut microbiome, systemic inflammation, the microtubule cytoskeleton, and right ventricular function in pulmonary arterial hypertension. During her training, she will refine skills that will enable her to perform clinically-relevant, translational research that will hopefully allow for future development of novel therapies for this rare and devastating disease.